Dynamics of oxidative DNA demethylation from duplex DNA to chromatin

Project Summary/Abstract
Methylation of cytosine bases in DNA to 5-methylcytosine (5-mC) acts as a key regulator in gene
expression for vertebrate animals and is associated with DNA packaging into heterochromatin. DNA
demethylation is initiated by ten-eleven translocation (TET) methylcytosine dioxygenases like TET2, which
oxidizes 5-mC, marking it for removed by thymine DNA glycosylase (TDG), which is then replaced by an
unmethylated C by base excision repair. It remains poorly understood how the presence of chromatin impacts
the efficiency of active DNA demethylation, although both TET2 and TDG interact with nucleosome core particles.
Preliminary studies from our lab have shown that TDG diffuses on DNA to search for modified bases, and
encountering nucleosomes can interrupt this search. Further, TDG was also demonstrated to interact directly
with TET2. Based on these findings, we hypothesize that TET2 and TDG act together and utilize NCPs as a
scaffold to efficiently remove methylated cytosines wrapped within. The experiments to test this hypothesis will
be performed in two phases. In the mentored K99 phase, the candidate will be trained in several new techniques,
including how to design and create knock-in cell lines with CRISPR/Cas9, perform single-particle tracking within
live cells, reconstitute nucleosome core particles, and generate high-resolution structures with cryo-electron
microscopy. This training will occur during AIM 1 where the candidate will determine the dynamics of TDG
diffusing and binding chromatin in living cells, as well as binding oxidized 5-methylcytosine on a defined DNA
tether in a single-molecule approach. Further, the structure of TDG on a nucleosome will be determined using
cryo-EM. Each training goal will be performed with respective experts in the field and will be complemented with
professional development courses at Pitt. In the independent R00 phase, the candidate will capitalize on these
new skillsets gained during AIM 1: in AIM 2, the candidate will use innovative techniques to generate site-specific
base modifications at defined genomic positions and chromatin states. Then, repair dynamics of TDG will be
tracked via single-particle tracking of live cells. In AIM 3, the skillset gained in AIM1 for TDG will be applied to
TET2, where the live-cell single-molecule dynamics of TET2 will be determined on duplex DNA and chromatin,
on endogenous levels of 5-mC and induced higher levels of DNA methylation. These results will be
complemented with studies of TET2 on long DNA tethers with defined substrates. Finally, in AIM 4, the candidate
will utilize the training in generating reconstituted nucleosomes to test how TET2 and TDG cooperate on
chromatin or on duplex DNA with enzymological, structural, and single-molecule approaches. These experiments
will provide mechanistic insights into how TET2 and TDG work together to achieve oxidative demethylation in
the context of chromatin. The training components of this project will supply the candidate with the skillset and
background to establish the basis of his independent work in his future academic career.

Public health relevance
Project Narrative Various environmental sources, including exposure to UV light and pollution, cause aberrations in DNA methylation patterns in the genome. In this proposal, I aim to study how DNA in duplex form or wrapped within nucleosomes is actively demethylated by thymine DNA glycosylase and ten-eleven translocation-2. By better understanding how DNA demethylation works on various chromatin states, this work will provide a meaningful contribution to how environmental exposures that alter DNA methylation can be mitigated.